PreCharge: An Innovative Digital Program to Increase Coping, Resilience, and Health Care Engagement Among Cancer Previvors

Hereditary Cancer Syndromes (HCS) account for approximately 5-10% of all diagnosed cancers. Inherited
genetic mutations resulting in HCS significantly increase the likelihood of developing cancer and pose risks
across generations. Previvors—individuals who test positive for HCS mutations—carry up to an 80% lifetime
cancer risk, face increased risks of developing multiple primary cancers, and often develop cancer at an early
age. Previvors confront distinct challenges, such as intensive surveillance that leads to “scanxiety,” health
uncertainties, and dual roles of managing their own health while also caring for relatives who have the same
mutation. Epidemiologic models estimate that 1 in 279 people may carry one of the most common HCS: Lynch
Syndrome. Advances in genetic testing have identified more inherited mutations and have made testing more
accessible, increasing the number of individuals diagnosed with HCS and raising concerns about programs and
services available to support previvors. Existing solutions are limited, underscoring the urgent need for
effective, scalable interventions designed to promote previvors’ mental health and emotional well-being.
Pro-Change has developed a digital intervention prototype, PreCharge, that is informed by the extensive
formative work completed in Phase I. The program includes assessments, tailored feedback and text message
communications, interactive activities and tools, and just-in-time assistance to enhance resilience and coping,
both of which are critical to previvor well-being. It does this using tailored communications created by a rule-
based AI engine and provide activities to assist previvors in: 1) getting informed; 2) navigating healthcare; 3)
processing difficult emotions; 4) getting social support; and 5) engaging in self-care. It proactively offers tools
to address "scanxiety" before medical appointments and users can text trigger words anytime for immediate
assistance or additional support. In a 1-month pilot test involving 134 previvors with low to moderate levels of
resilience, PreCharge was well received, demonstrating: statistically significant pre-post improvements in
confidence to cope; notable pre-post improvements in resilience and psychological flexibility; and decreases in
symptoms of anxiety and depression among participants. The proposed Phase II work aims to fully develop the
PreCharge program, incorporating what was learned in the pilot, which will provide a more personalized,
interactive, and integrated program experience. In the proposed Phase II work, the fully developed PreCharge
program will be evaluated for its efficacy, engagement, and acceptability in a 6-month trial involving 574
previvors. Participants will be randomly assigned to a treatment or assessment-only control condition. Efficacy
will be assessed by comparing changes in confidence to cope at 3- and 6-month follow-ups, as well as changes
in secondary outcomes including anxiety, depression and resilience. Successful completion of Phase II will
position PreCharge as an evidence-based previvor well-being intervention to be disseminated to genetic testing
providers, genetic counselors, wellness platform providers, and other organizations.

Public health relevance
8. Project Narrative In the US, at least one out of every 300 people is a previvor—an individual diagnosed with a Hereditary Cancer Syndrome (HCS) who has not developed cancer—and faces significant challenges, including elevated cancer risks, intensive surveillance which leads to “scanxiety,” health uncertainties, and dual roles of managing personal health while caring for relatives with the same mutation. The proposed Phase II research will build on the successful prototype development and pilot testing by rigorously evaluating the effects of the fully developed PreCharge program, a digital intervention that provides tailored guidance on resilience and coping, both of which are critical to previvor well-being. As genetic testing continues to advance and diagnoses of HCS increase, PreCharge offers a science-based, scalable, and easily disseminable solution to meet the unique mental health and emotional well-being needs of the growing previvor population.